Comprehensive identification of RAS mutations and allelic co-segregation patterns in colorectal cancer

Project Summary
Colorectal cancer (CRC) is the fourth most common cancer, and the second leading cause of cancer death in
the United States. Activating oncogenic mutations in KRAS or NRAS are found in >45% of CRC, driving tumor
progression and influencing efficacy of both cytotoxic and targeted therapies; these mutations often co-occur
with mutations of other oncogenes and tumor suppressors, including APC, TP53, BRAF, PI3KCA, and others.
Importantly, structure-function analysis of relatively common RAS mutations in G12, G13, Q61, and other codons
indicate these have non-equivalent transforming potential and modes of action. These differences can have
clinical impact; for example, G12 mutations confer resistance to EGFR-targeting drugs, but G13D mutations do
not. Our goal is to better understand the significance of KRAS mutations in CRC, and to leverage this work to
better stratify CRC patients for selection between treatment options. In preliminary studies, using a dataset of
13,000 CRC specimens, we have investigated genomic patterns of variance in RAS-family proteins in CRC.
From this recently published work, we have identified novel hotspot mutations, and revealed striking differences
in RAS mutational pattern occurring in distinct patient subgroups, based on microsatellite instable (MSI) versus
microsatellite stable (MSS) status, colon versus rectum as primary tumor subsite, patient age, and in one case,
patient sex. In a second study, we have also identified age-related patterns of mutation of additional driver genes,
including APC, BRAF, and FAM123B, characterizing distinct patient subgroups. However, we were limited by
the study sample size from addressing a number of important questions; in particular, whether specific alleles of
KRAS and NRAS segregated with mutations in additional driver genes in a manner that predicted signaling
pathway dependency in specific patient subgroups. Our goal is to address these and other questions in detail,
using information for ~34,000 CRC tumors provided by Foundation Medicine, and for ~8,400 CRC tumors we
compiled from public datasets. To this end, we propose two Aims. In Aim 1, we will identify the complete
repertoire of RAS hotspot mutations, including 3D hotspots. We will align hotspots to RAS structures, and
establish their covariance with clinicopathological variables (including tumor subsite, age, sex, tumor mutation
burden (TMB, including specific consideration of hypermutated tumors), and MSI/MSS status) and underlying
targeting of trinucleotide contexts associated with specific mutational processes. We will analyze mutational
patterns that differ between the two primary KRAS isoforms, KRAS4B and KRAS4A, given recent data
suggesting an important specific role for KRAS4A. In Aim 2, we will elucidate gene, codon, and variant level
analysis of co-occurrence of RAS mutations with other driver genes commonly mutated in CRC, and we will
determine whether co-variance patterns differ based on clinicopathological features. Analysis of the context
(comutational patterns) for specific alleles will help define allelic function and clinical actionability for distinct
patient cohorts.

Public health relevance
Project Narrative Colorectal cancer (CRC) is the fourth most common cancer and the second leading cause of cancer death in the United States. Over 50% of CRCs are driven by activating oncogenic mutations in RAS genes; using a uniquely large CRC genomic dataset, we are investigating patterns of RAS gene mutation, including co- segregation or mutual exclusion of RAS mutations with other driver lesions, to better understand activation of downstream signaling events that control tumor aggressiveness. These data will help to determine whether specific RAS mutational hotspots, alone or in combination with other mutations, are prognostic of outcome, or identify therapeutically targetable vulnerabilities in sub-populations of CRC patients.